Mutation-Specific Calmodulin Kinase II Activation in Hypertrophic Cardiomyopathy

Project Summary:
Hypertrophic cardiomyopathy (HCM) is the most common genetic cardiomyopathy, affecting ~1/300-1/500
individuals worldwide. In the clinic, HCM displays a high degree of phenotypic variability which presents major
challenges regarding targeted therapeutics and determining the mechanisms which drive disease progression.
HCM has been definitively linked to mutations in genes encoding the protein components of the cardiac
sarcomere, including the cardiac thin filament (CTF). The CTF is an essential regulator of sarcomeric contraction
and couples the availability of cytoplasmic calcium to force development. Previous work has shown that in human
late-stage HCM samples, there are increased levels of Ca2+/Calmodulin-dependent kinase IIδ (CaMKIIδ)
phosphorylation and oxidation. Both post-translational modifications, along with several others, render the kinase
autonomous of its physiological regulation via calcium, increasing kinase activity. As CaMKIIδ targets several
proteins which maintain electromechanical and calcium homeostasis, increased activity has high
pathophysiological potential and has been noted in several cardiac diseases in addition to HCM. Our lab has
demonstrated that this increase in autonomous CaMKIIδ activity is dependent on the specific point mutation in
the CTF. Specifically, increased CaMKIIδ is observed in mice expressing the R92W mutation in cardiac troponin
T (cTnT), but not in mice expressing the R92L mutation. This mutation-specificity suggests that there are specific
primary alterations in biophysical properties of the CTF, which can be altered in differing fashions by mutations,
that act as triggers for increased CaMKIIδ activity. To the best of our knowledge, these specific alterations, and
the mechanisms by which they increase CaMKIIδ activity, have yet to be investigated. We hypothesize that
increased CaMKIIδ activity is a result of early, myofilament-based calcium dysregulation, specifically accelerated
calcium dissociation kinetics from the CTF, and that the increased activity drives pathological remodeling and
thus can be a therapeutic target in a subset of HCM. In Aim 1 we will perform experiments utilizing mass
spectrometry, a novel CaMKIIδ biosensor, and sarcoplasmic reticulum calcium uptake techniques to define
CaMKIIδ activity and the state of calcium dysregulation in three separate mouse models of HCM which express
mutations in cTnT associated with HCM: R94H, I79N, and R92W. We will use these data to determine whether
calcium dysregulation stemming from acceleration of calcium dissociation kinetics is strictly associated with
increased CaMKIIδ activity. In Aim 2 we will assess the efficacy of the small molecule CaMKIIδ inhibitor
ruxolitinib, currently FDA-approved for various bone marrow and skin diseases as a Janus kinase 1/2 inhibitor
to alter pathogenic remodeling in HCM in vivo. We will treat cTnT-R92W mice at early- and late-stage disease
to determine if CaMKIIδ inhibition can be a viable treatment option at any point in disease progression or only at
specific times. The data from these experiments will identify new links between molecular phenotypes, provide
new insight into mechanisms of HCM progression, and describe a novel therapeutic target for cTnT-linked HCM.

Public health relevance
Project Narrative: Ca2+/Calmodulin kinase IIδ (CaMKIIδ) is a key regulator of electromechanical and calcium homeostasis in cardiac myocytes, and dysregulation in the form of overactivation is a mutation-specific driver of pathogenesis in hypertrophic cardiomyopathy. This proposal focuses on deciphering the myofilament-based, mutation-specific mechanisms by which this dysregulation occurs and establishing small molecule CaMKIIδ inhibition as a therapeutic option for hypertrophic cardiomyopathy patients. We propose a variety of in vivo experiments to investigate CaMKIIδ activation and activity, calcium handling, and small molecule CaMKIIδ inhibition in hypertrophic cardiomyopathy mouse models.